Opioid/benzodiazepine polydrug abuse: Integrating research on mechanisms, treatment and policies

PROJECT SUMMARY / ABSTRACT
Significance: Benzodiazepine (BZD)/opioid polysubstance abuse (PSA) confers significant risks of overdose,
disability and death; yet, little is known about phenotypes that could be targeted to decrease these risks. We
will address this multi-faceted problem at population, clinical and human laboratory levels of analysis, using the
integrative and translational focus of PAR-16-291. This project’s unifying hypothesis is that BZD/opioid PSA
is maintained by a dual-deficit in affective regulation (phenotypes: high anxiety-sensitivity/distress-intolerance
and hedonic deficit/reinforcement pathology, building on Koob’s reward-deficit/stress-surfeit model), associated
with impaired neurocognitive and behavioral functions, relative to BZD or opioid use alone. Goals: Our
interdisciplinary team (experts in epidemiology, biostatistics, clinical assessment, and human behavioral
pharmacology) will use rigorous and complementary mixed methods to test our unifying hypothesis in this
sequential R21/R33 approach. Aim 1 (R21): Determine from behavioral health treatment records the
prevalence of patient presentation with opioid, BZD or BZD/opioid PSA and associations of substance-use
patterns with affective symptoms (primarily anxiety and depression), physical comorbidities (primarily chronic
pain), medications, demographics, and treatment outcomes. This analysis will provide a context for assessing
generalizability of findings from Aim 2 (in-depth clinical assessment) and Aim 3 (human laboratory). Aim 2
(R21): In a sample of newly admitted behavioral health patients, rigorously evaluate and characterize deficits
across domains (affective, neurocognitive, behavioral) in opioid, BZD and BZD/opioid PSA and pattern of
substance use (especially simultaneous vs concurrent BZD/opioid PSA, alcohol use). Aim 3 (R33): Among
community-recruited research volunteers (non-treatment seekers) with a recent history of BZD/opioid PSA, test
whether: (3a) substance abuse severity among BZD/opioid PSA influences affective, neurocognitive and
behavioral measures (using the refined assessment battery from Aim 2) including more lifetime drug-use
consequences, and greater price-inelasticity for opioid and BZD using behavioral economic simulations; and
(3b) experimental drug administration of alprazolam/morphine vs. either drug alone or placebo (with dose-
response evaluation) will differentially alter affective/hedonic phenotypes in three different behavioral choice
procedures: (i) increase price-elasticity of drug demand, (ii) shift preference away from avoiding aversive
stimulation toward positive reinforcement, and (iii) increase monetary delay discounting. Overall impact: This
multi-level, integrated approach will test our unifying hypothesis that BZD/opioid PSA is maintained by a dual-
deficit in affective/hedonic regulation, with related neurocognitive and behavioral impairments. By translating
findings from population and clinical levels to laboratory-based approaches, this project will begin to address
the complex and harmful nature of BZD/opioid PSA with longer-term objectives of advancing mechanistic
understanding, improving treatment outcomes, and policies to reduce risks of overdose, disability and death.

Public health relevance
PROJECT NARRATIVE To address objectives of PAR-16-291, we focus on harmful benzodiazepine (BZD)/opioid polysubstance abuse (PSA). We will test our unifying hypothesis that BZD/opioid PSA is maintained by a dual-deficit in affective regulation (reward-deficit/stress-surfeit model) with associated impairments in neurocognition and adaptive behaviors. To address this multi-faceted problem, we will use population, clinical, and laboratory-level studies and translate our findings to address the harmful nature of BZD/opioid PSA, toward advancing mechanistic understanding, improving treatment outcomes, and policies to reduce risks of overdose, disability and death.